Administrative Core

Project Summary/Abstract of the Administrative Core
The Administrative Core (AC) will serve to support and integrate the activities conducted by the Translational
Research Program in Colorectal Cancer Disparities (TRPCD) including the Full Projects, the Biospecimen and
Pathology Core (BPC), and the Developmental Research Program (DRP). Additionally, as part of this Core, we
will develop and initiate a Career Enhancement Program (CEP) to identify and support promising junior
investigators, and those new to the field of cancer disparities. The AC will provide formal coordination of efforts
involving the following entities:
1. All TRPCD investigators
2. The Executive Committee (EC) and Advisory Boards, including the External Advisory Board (EAB), the
Internal Advisory Board (IAB), and the Community Advisory Board (CAB)
3. Review Panels evaluating applications to the DRP
4. Representatives of the National Cancer Institute
5. New external partnerships built through this program including, but not limited to, those involving existing
SPOREs and other funded disparities P20 programs
This Core has the following specific aims:
Aim 1. To provide the organizational structure, leadership, and administrative support requisite for successful
execution of key TRPCD objectives.
Aim 2. To coordinate TRPCD activities with various projects, programs, and shared resources at participating
institutions such that integration of these existing institutional resources will successfully support the
TRCPD and lead to the development of a full P50 SPORE application.
Aim 3. To do the following planning and evaluation activities: organize regular EC/EAB/IAB/CAB meetings,
provide rigorous fiscal oversight and management while ensuring compliance with all relevant
institutional requirements, provide career development opportunities to investigators (including
development of a SPORE-caliber CEP), maintain open lines of communication with NCI, initiate and
sustain collaborations with key external partners, and monitor and update a transition plan to a full P50
SPORE grant.

Public health relevance
Project Narrative of the Administrative Core The continuing and successful functioning of the Translational Research Program in Colorectal Cancer Disparities (TRPCD) is highly dependent upon a capable and effective Administrative Core (AC). The AC will be vital for providing the requisite foundation for effective implementation of the TRPCD’s scientific and translational goals. This Core will comprise overall management, infrastructural support, education, and communication within and across the TRPCD investigators and institutions.